BubRI in Cancer and Aging

PROJECT SUMMARY/ABSTRACT
Age is the most important risk factor for cancer and other debilitating or life-threatening conditions, but how
biological processes change with aging at the molecular level and how these changes contribute to cellular,
tissue, and organismal dysfunction remain largely unknown. Filling these gaps in our knowledge is critical for
understanding both cancer and aging. Rare autosomal-recessive childhood disorders characterized by cancer
and premature aging, such as Mosaic Variegated Aneuploidy (MVA) syndrome, are increasingly recognized as
powerful tools for advancing knowledge about fundamental biological processes at the cancer-aging interface.
Most MVA cases are linked to mutations in BUBR1, a mitotic checkpoint gene required for proper chromosome
segregation. Our long-term goal is to uncover the full spectrum of BubR1 biological functions, define how
deficiencies in BubR1 contribute to the development of cancer and other aging-related diseases, and apply the
information thus gained to develop innovative therapeutic strategies that will lead to better health for many. As
the next step in the pursuit of this goal, our objective here is to understand mechanistically how BubR1
insufficiencies induce cellular senescence and enhance growth factor receptor (GFR) signaling to drive age-
related carcinogenesis, and to assess whether aneuploidy and senescence resulting from BubR1 aberrancies
activate immune surveillance mechanisms. Based on our preliminary data, we hypothesize that BubR1
insufficiencies drive cellular senescence through unscheduled activation of Wnt/β-catenin signaling, promote
neoplastic growth by disrupting GFR endocytosis, and engage the cGAS-Sting cytosolic DNA sensing pathway
as a fail-safe mechanism to eliminate senescent and aneuploid cells via the immune system. We propose to
test this hypothesis by pursuing three specific aims. In the first aim, we will determine how BubR1 insufficiency
drives senescence-mediated premature aging using pharmacological and genetic approaches to inhibit β-
catenin activity in BubR1 progeroid mice. In the second aim, we will establish whether and how BubR1
insufficiencies impair internalization of cancer-associated GFRs by using MVA patient cell lines and MVA
mouse models. In the third aim, we will assess the in vivo relevance of cytoplasmic genomic DNA sensing by
cGas-Sting in senescence, aneuploidization, cancer and aging using mouse models for BubR1 insufficiency
and chromosomal instability combined with Sting knockout mice. The expected overall impact of this innovative
proposal is that it will vertically advance our understanding of how a prominent mitotic checkpoint protein
safeguards against two significant human health problems, cancer and aging, and how deficiencies of BubR1
disrupt its multifaceted functions in the cell. Importantly, the results are expected to have a positive impact
because they will likely pave the way towards transformative clinical interventions for treating or preventing a
broad spectrum of human cancers and a subset of age-related diseases that limit healthy lifespan, in addition
to conceptually advancing the fields of mitosis, signaling, cancer, and aging.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it is expected to fundamentally advance our mech- anistic understanding of a multifunctional mitotic regulator, BubR1, that is implicated in two major human health problems, cancer and aging. We expect this knowledge to pave the way towards transformative clinical inter- ventions for treating or preventing a broad spectrum of human cancers and age-related diseases that limit healthspan.